Innovative Pain and Symptom Management Program for Children with Cancer

Every year over 12,000 children will be diagnosed with cancer in the United States and distressing symptoms,
such as pain, fatigue, and nausea, are experienced by the majority of these children across all cancer
diagnoses. Suboptimal pain and symptom management has the potential for both immediate and long-term
effects on children’s physical, social, and emotional functioning. The transition to outpatient care has resulted
in a lack of systematic symptom assessment in children undergoing cancer treatment, which results in limited
data for healthcare providers regarding children’s symptom experience in the home setting. In addition, current
programs targeting pain in children in the home setting are largely limited to assessment tools and do not use
patient-reported outcomes or capitalize on the ability of technology to deliver evidence-based pain
management skills. Based upon this gap in the literature, we developed a web-based pain and symptom
management intervention (Pain Buddy) that incorporates validated patient-reported measures of pain and
symptoms in children with cancer, uses an electronic server to deliver child-reported symptom data in real time
to healthcare providers, incorporates symptom alert algorithms to notify providers when a child has reported
clinically significant symptoms, and teaches children empirically-supported cognitive and behavioral skills for
pain management. A small pilot trial successfully demonstrated positive effects of Pain Buddy on pain severity
in children undergoing primarily outpatient cancer treatment. The proposed randomized trial of two children’s
cancer centers will examine the efficacy of Pain Buddy on decreasing symptom severity and improving quality
of life in children with cancer. The primary aim of the study is to determine if Pain Buddy is more effective than
attention control in reducing pain severity among children ages 8-18 years old undergoing outpatient cancer
treatment. Secondary aims of the study are to: 1) Examine the impact of Pain Buddy on symptom-related
distress, health-related quality of life, child functional status, and child and parent satisfaction with treatment
experience; and 2) Identify baseline characteristics of children (anxiety, pain catastrophizing) and parents
(stress, attitudes regarding analgesic use for children) that may moderate/mediate treatment outcomes. This
project paves the way to establish effectiveness of Pain Buddy and ultimately transform care to improve the
quality of life of tens of thousands of children suffering from cancer each year.

Public health relevance
The proposed study will examine the efficacy of an innovative, web-based pain and symptom management intervention for children undergoing primarily outpatient cancer treatment. The focus of this application, pediatric cancer pain, is of extremely high public health significance given the large numbers of children diagnosed with cancer each year, the significant under treatment of pain in this population, and the effects of untreated pain on children’s physical, social, and emotional health. This intervention has the potential to impact not only the tens of thousands of children diagnosed with cancer each year, but has widespread applicability to manage pain associated with a wide variety of illnesses.